Home Oxygen Use for Infants with Bronchopulmonary Dysplasia: Balancing Infant, Family, and Health System Outcomes

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to provide a pathway to independence as a clinical investigator in healthcare
utilization and health-related quality of life (HRQL) assessment, applied to outcomes research for infants with
bronchopulmonary dysplasia (BPD). Infants with BPD are at high risk for prolonged NICU stays, readmissions,
and developmental delay. Home oxygen is used commonly to facilitate earlier hospital discharge, but there is
wide variation across U.S. hospitals in use of this therapy. My recent study showed that infants with BPD in
centers using more frequent home oxygen had a 1.2-week shorter average NICU stay than infants in centers
using less frequent home oxygen, adjusted for illness severity. There is a gap in knowledge of how home
oxygen impacts infant outcomes after NICU discharge, and how it affects their families. I would like to develop
a unique niche assessing healthcare utilization and HRQL after NICU discharge, to generate evidence-based
NICU discharge guidelines that optimize infant health outcomes with minimal undue burden on families. I will
begin to achieve these goals by engaging in a career development plan that logically extends my prior training
in neonatology and epidemiology. I will build skills in prospective study leadership, health services outcomes
measurement, and developmental and HRQL assessment. This career development plan will be guided by
experienced mentors and a scientific advisory committee at the Medical College of Wisconsin with expertise in
pediatric healthcare utilization, HRQL for children with chronic illness, BPD clinical outcomes research,
advanced quantitative analysis, developmental assessment, and neonatal bioethics. This mentorship and
career development plan are integrated with research investigating outcomes of infants with BPD after NICU
discharge, focusing on differences following home oxygen use. The first aim seeks to determine whether home
oxygen use for infants with BPD is associated with increased readmissions in the year after NICU discharge,
matched on illness severity and demographic risk factors. This will be assessed via a secondary analysis of
data from the Children’s Hospitals Neonatal Database, a multi-center cohort of 25 Level IV children’s hospital
NICUs with linked post-discharge readmission data available via the Pediatric Health Information System. The
second aim will prospectively compare infant and parent outcomes for infants with BPD discharged from the
Children’s Hospital of Wisconsin NICU with and without home oxygen from NICU discharge through 2 years of
age. The prospective study will measure infant healthcare utilization and parent HRQL over time after NICU
discharge, and study the relationship between those factors and 2-year outcomes. Results will provide
outcome comparisons for infants with BPD discharged with and without home oxygen therapy, and assess how
a specific NICU therapy affects parent HRQL over time. This can be used in making evidence-based decisions
about NICU discharge planning. Results and expertise acquired during this award will be used to test the
impact of a multi-center intervention implementing consistent guidelines for home oxygen use.

Public health relevance
PROJECT NARRATIVE Although bronchopulmonary dysplasia (BPD) can lead to worse long-term health of preterm infants, there is a lack of understanding of how medical therapies such as home oxygen affect the health and development of infants with BPD after they leave the NICU, or how such therapies affect families. The proposed research will compare infants who went home on oxygen with those who did not, in terms of health, development, and quality of life. Infants with BPD and their families will be followed from NICU discharge through 2 years of age.